Developing Evidence To Inform Regulatory Policy On Nicotine Content In E-Liquids

Summary Abstract
Regulation currently relies heavily on machine-generated emissions to predict harmful and potentially harmful
constituent (HPHC) exposure from using products under review, without a good understanding of how the
product will impact public health under real-world conditions. This study addresses the question of whether
ecig users who currently choose to use lower nicotine eliquids are actually consuming less nicotine compared
to those who choose to use higher nicotine eliquids. We will provide evidence on the extent to which using low
nicotine eliquids reduces one’s overall exposure to HPHC. We will monitor N=120 pod and pen-style regular
ecig users in their natural environment for one week, collecting ambulatory topography data using RIT’s
wPUMTM monitors along with daily salivary cotinine, subject effects and exposure and health effect biomarkers.
Data will be evaluated in the context of the joint effect of product characteristics and behavior on product
emissions and, ultimately, on public health. Aim 1: Evaluate HPHC exposure using the traditional approach of
salivary cotinine, a well-accepted biomarker for nicotine exposure, and other urinary and salivary biomarkers of
exposure and adverse health affect. Aim 2: Evaluate HPHC exposure using a novel alternative outcome
measure we call behavior-based yield, which incorporates one-week of intensive puff-by-puff topography and
product-specific emissions, Aim 3: Add pharmacokinetics to improve the predictive utility of the behavior-
based yield model by incorporating personalized reaction kinetics, which will then be applied to predict the
time-course of salivary cotinine for one-week of natural use. We expect the outcomes to support the
premise that exposure to both nicotine and total particulate matter are important in risk assessment,
and the potential to inadvertently increase one by decreasing the other must be considered when
making product choices and regulatory decisions. This project will; (1) Provide evidence that regulating
nicotine concentration alone does not reduce nicotine uptake, nor reduce adverse health effect; (2) Provide
device-independent evidence that users of lower nicotine eliquids do not consume less nicotine and may
consumer more total particulate matter compared to users of higher nicotine eliquids; (3) Provide evidence
supporting the need for rigorous accounting of behavior when reporting HPHC exposure in PMTA and MRTP
applications; and (4) Provide evidence in support of establishing a causal relationship between tobacco
product characteristics and health effect.

Public health relevance
Project Narrative The extent to which electronic cigarette users may compensate for lower nicotine eliquids by consuming more product has particular implications on the effectiveness of clinical and regulatory interventions. Decisions to use reduced nicotine products or regulations limiting nicotine concentration in eliquids may not reduce nicotine consumption. In fact, such decisions might result in adverse health effects arising from increased consumption of harmful constituents. This project aims to provide evidence to inform regulatory policy on nicotine content in e-liquids by elucidating how nicotine absorption in the body is jointly affected by e-liquid nicotine concentration and vaping behavior.